EFFECT OF THYROID STATUS ON THE DYNAMICS OF THE ADRENAL AND REPRODUCTIVE AXES

This study will define the influences of deficient and excess circulating levels of thyroid hormone on the pulsative secretion and regulation of the hormones of the hypothalamic-pituitary and adrenal axis.